Revealing the Role of Lipid-Laden Macrophages in Staphylococcus aureus Osteomyelitis Abscess Formation

ABSTRACT
Inflammation of the bone or bone marrow, known as osteomyelitis, is most frequently caused by
Staphylococcus aureus infection, with the prevalence of this pathogen making osteomyelitis a critical disease
state to study. Bone possesses a unique cellular environment and serves a critical role in producing immune
cells, including the differentiation of hematopoietic stem cells into monocyte precursors. S. aureus is capable
of surviving via various mechanisms, such as the formation of abscesses in the bone marrow. These
characteristic tissue lesions contain a central staphylococcal abscess community surrounded by both viable
and necrotic neutrophils and are encapsulated by fibrin deposits. Previous work in our laboratory suggested
the presence of a unique set of macrophages with a lipid-laden phenotype localized to the outer border of the
abscess. Macrophages are innate immune cells recruited to the site of infection to phagocytose invading
pathogens and recruit additional immune cells. Heterogeneous macrophage phenotypes have previously been
described using techniques like flow cytometry, but spatial interrogation of heterogeneous macrophage
populations and physiology has been difficult. Given the presence of lipid-laden macrophages around the
abscess border and previous studies indicating the necessity of macrophage-derived factors for adequate
abscess formation, I hypothesize that lipid-laden macrophages mediate abscess formation in the context of S.
aureus-induced osteomyelitis, exhibiting anti-inflammatory molecular profiles and facilitating a protective niche
for the SAC. Understanding the overall tissue architecture and localization of these cells in relation to the
abscess is crucial, prompting the use of a multimodal imaging approach to assess this hypothesis. Matrix-
assisted laser desorption/ionization (MALDI) imaging mass spectrometry (IMS) is a label-free analytical tool
capable of detecting hundreds of analytes within a tissue section with high specificity and sensitivity. My
research group has pioneered new approaches for IMS of bone that will provide an unprecedented view of the
lipid landscape in the context of osteomyelitis. Furthermore, spatial transcriptomics is a powerful, untargeted
technique for identifying gene transcripts present within specific tissue regions. The novel integration of MALDI
IMS and spatial transcriptomics in bone tissue, as proposed in Aim 1, will provide a comprehensive view of the
impact of S. aureus on the bone and how macrophages impact the infection response. To further interrogate
the role of macrophages in staphylococcal abscess formation, I will use multiple approaches to deplete these
cells in our murine osteomyelitis model followed by the integrated multimodal imaging workflow. Additionally, I
will establish a lipid-laden macrophage cell culture model, as described in Aim 2, to resemble the molecular
profile observed in vivo and to characterize their interactions with S. aureus. These data will provide insight into
the pathological progression of S. aureus infections and lipid-laden macrophage-induced inflammatory
responses employed to fight off infection in the unique bone marrow microenvironment.

Public health relevance
PROJECT NARRATIVE Osteomyelitis, or inflammation of the bone, is a debilitating disease requiring intensive antibiotic administration or surgical debridement for effective treatment. Staphylococcus aureus is the leading cause of osteomyelitis and is capable of seeding infections and forming abscesses in the bone marrow, allowing for enhanced bacterial survival. The proposed multi-omic approach will identify interactions between S. aureus and lipid- laden macrophages and provide a detailed spatiomolecular view of the host-pathogen interface, informing novel therapeutic options.